The Caribbean Cancer Research Center on Environmental and Natural Hazards

Project Summary Overall Component
Climate change is a threat to human health which impacts each step of the cancer control continuum. Frequent
extreme weather events in the US Caribbean (Puerto Rico [PR] and US Virgin Islands) have highlighted the
interdependencies of their critical infrastructure systems, and how their disruption leads to catastrophic failures
in social and economic ecosystems, with fatal and long-lasting consequences. These US Territories where
cancer is among the leading causes of death, have suffered major disruptions in cancer prevention and screening
programs, and delays in cancer diagnosis and treatment as a result of extreme weather events. Preventing
cancer risk and sustaining infrastructure for cancer control after these events are priorities. The Caribbean
Climate Change, Cancer, and Health Disparities Research Center (CCCARIB-CARES) will address these
issues. A partnership between the University of PR Comprehensive Cancer Center, the University of PR-Medical
Sciences Campus, and the University of the Virgin Islands, alongside government agencies, and non-
governmental organizations based in the US Caribbean region and the continental US, will work collaboratively
to assess the impact of multi-hazard climate change-related stressors on the cancer control continuum across
these populations. The main goal of CCCARIB-CARES is to increase and support the research and governance
capacity of underserved and underrepresented minorities with respect to climate change and health. Using a
human-centered design, the specific aims of CCCARB-CARES are: 1) To form a regional knowledge-action
network of researchers, physicians, stakeholders and community residents, public and private institutions
working on the cancer continuum that can evaluate needs, provide technical-scientific expertise, facilitate
communication, and build cross-regional connections and capacity on climate change, environmental pollution
and cancer risk, prevention and control, as well as health disparities in the Caribbean region; 2) Increase the
number of students and researchers from the Caribbean region conducting research on the impact of climate
change and pollution on cancer prevention and control and health disparities, with the intent to mitigate the
burden of environmental stressors on human health and health disparities among underrepresented minorities
and underserved communities in the region; 3) Establish a Community Coalition of Partners to develop and
strengthen sustainable strategic collaborations with stakeholders, community-partners, academic, nonprofit and
government-based organizations to promote scientific and community-focused activities aimed at reducing the
impact of climate change and pollution on cancer prevention and control and health disparities among vulnerable
and underserved populations; and 4) Provide capacity-building activities for community members, students and
faculty in climate change and health, to strengthen community and academic infrastructure and capacity through
outreach, interventions and research. CCCARIB-CARES includes multi-centric and integrated Administrative
and Community Engagement Cores and a mixed-methods research project to guide the proposed efforts.

Public health relevance
Narrative The US Caribbean is vulnerable to climate change and its impact on the cancer control continuum. The Caribbean Climate Change, Cancer and Health Disparities Research Center (CCCARIB-CARES) will increase capacity at PR and USVI to develop, support, and sustain education, capacity building, research, and adaptation capacities to help mitigate the impact of climate change in cancer prevention and control and health disparities in these populations. CCCARIB-CARES will increase and support the research and governance capacity of underserved and underrepresented minorities in the Caribbean, with respect to climate change.